The Impact of Parent/Caregiver Behavioral Health Interventions on Child Outcomes

PROJECT SUMMARY/ABSTRACT
Broad Objectives: The goal of the proposed project is to improve understanding of how interventions to prevent
and treat parents’ behavioral health (BH) problems impact their children, and how the impact varies for different
types of interventions, children, parents, and families. The applicant’s primary career objective is to develop a
program of research focused on identifying, developing, and improving the dissemination and implementation of
effective approaches to prevent negative consequences of youth and family BH problems on a population level.
Specific Aims: The proposed project aims to (1) map and characterize the existing body of research that has
tested the effects of parent-focused BH interventions on children, and (2) synthesize existing evidence regarding
the impact of parent-focused BH interventions on child outcomes in order to: (a) determine whether and to what
extent existing parent-focused BH interventions can reduce the risks that parent BH problems pose to children,
and (b) identify potential moderators and mechanisms of intergenerational risk transmission and prevention, by
evaluating how the impact of parent-focused BH interventions on children varies in relation to key characteristics
of the intervention, the child, or their parent(s) and family.
Method: Two broad-based reviews, a scoping review and a meta-analysis, will integrate findings from primary
research testing interventions for the full spectrum of parent BH problems and full range of child outcomes. The
scoping review will first map all available relevant evidence, and its results will guide design of the meta-analysis.
The meta-analysis will estimate the average effect of parent-focused BH interventions on child outcomes, and
moderator analyses will examine how effects vary in relation to characteristics of the intervention, the child, their
parent(s) and family, and the study methods. A series of meta-regression analyses will assess the extent to
which an intervention’s effectiveness in reducing parent BH problems predicts its impact on child outcomes.
Significance: Parent BH problems are risk factors for a wide range of adverse child outcomes, but little is known
about whether or how much interventions that successfully treat and/or prevent parent BH problems result in
improved outcomes for their children. Study findings will advance understanding of the role that parent-focused
BH interventions can play in improving the lives of children, and will inform policy, practice, and research efforts
that seek to mitigate the multigenerational consequences of parent BH problems.
Training Plan: Through a combination of (a) individual meetings and consultation with expert mentors, (b) group
research meetings, (c) formal coursework, (d) conferences and workshops, and (e) productive research
activities, the applicant will (1) develop expertise in how transgenerational risks associated with parent BH
problems are transmitted and prevented, (2) gain advanced training in methods for synthesizing existing
research evidence, (3) develop expertise and skills in open science best practices for transparent, reproducible
research, and (4) build critical experience and skills for effectively communicating science to diverse audiences.

Public health relevance
PROJECT NARRATIVE Parent behavioral health problems are risk factors for a wide variety of adverse child outcomes, but little is known about whether or how much interventions that successfully treat and/or prevent parents’ behavioral health problems result in improved outcomes for their children. The proposed project will improve understanding of how children are affected when their parents receive behavioral health interventions, and how the impact differs for different types of interventions, children, parents, and families. This knowledge will inform and advance future policy, practice, and research efforts to improve the lives of children and adolescents whose parents are affected by behavioral health problems.